Randomized Controlled Trial of AboutFace: A Novel Video Storytelling Resource to Improve Access, Engagement, and Utilization of Mental Health Treatment among Veterans with PTSD

Anticipated Impacts on Veterans Health Care: Behavioral health problems among Veterans have raised
awareness of the critical need for more reliable, effective, and accessible means to recognize those in need,
direct them to help, and ensure that they receive the best treatment available. Research has suggested that
people are most responsive to advice and education when it comes from someone to whom they can relate.
AboutFace is a peer education resource for Veterans that was developed, launched, and recently updated
by the National Center for PTSD (NCPTSD) based on HSR&D funded pilot data. AboutFace features
personal stories of Veterans and is designed to improve mental health treatment engagement among
Veterans with PTSD and related comorbidities. The study team, which includes the NCPTSD, recently
completed a usability assessment and pilot feasibility trial of AboutFace under HSR&D grant #PPO 14-360-
1. Data from this study (1) guided improvements to AboutFace for increasing PTSD treatment initiation and
engagement; and (2) demonstrated the feasibility of the methodology for the proposed study. If AboutFace
is found to increase Veterans’ initiation and engagement in PTSD treatment, study data will have broad
implications for overcoming barriers to care for Veterans with PTSD and other stigmatized conditions.
Background: At least 1 in 10 Veterans meet criteria for PTSD related to their military experience. Treatment
for PTSD is widely available, and national dissemination initiatives have increased Veterans’ access to best-
practice interventions. However, treatment-seeking remains strikingly low; most Veterans with PTSD do not
seek mental health services due to perceived stigma and other barriers. NCPTSD developed and launched
AboutFace, a public awareness campaign to help Veterans recognize PTSD and motivate them to seek
evidence-based care. Since its development, AboutFace has earned three major awards and has had tens
of thousands of visits. Despite the tremendous potential for AboutFace to reduce stigma, improve attitudes
toward mental health treatment seeking, and to increase PTSD treatment initiation and engagement, it has
yet to be formally evaluated or effectively implemented within VHA practice settings. In addition to providing
needed data on the efficacy of AboutFace and identifying strategies for effective implementation within VHA,
this study will provide a greater understanding of the role and value of digital storytelling interventions to
improve access to care for a wide range of stigmatized conditions.
Objectives: The primary objectives of the study are to examine the impact of AboutFace on a) increasing
PTSD treatment initiation and engagement; and b) decreasing stigma and negative attitudes toward mental
health services. It is anticipated that Veterans in the AboutFace condition will be more likely to access and
complete treatment than those receiving enhanced Usual Care (eUC) for PTSD. Finally, qualitative
interviews with key stakeholders across the nation will be conducted to inform best practices for future
implementation of AboutFace.
Methods: A total of 376 Veterans referred for a PTSD assessment and recommended for treatment in the
Charleston PTSD clinic will be enrolled in the study. Veterans will be randomized to receive AboutFace
versus eUC. All Veterans will receive standard PTSD educational materials, and half will also be randomly
assigned to receive AboutFace. Comparisons will be made across indices of treatment engagement [i.e.,
initiated treatment (yes/no), total number of sessions completed;]; changes in stigma and attitudes toward
seeking mental health treatment; and changes in PTSD symptoms and quality of life. Veterans will be
assessed on these indices at baseline, 1-month, 3-month, and 6-months. Thematic interviews will be
conducted with 20-30 VA PTSD Clinical Team Directors from a diverse range of PTSD clinics (i.e., ranging
in size, location, and practice) to inform future implementation and dissemination initiatives.

Public health relevance
Narrative Behavioral health problems among Veterans have raised awareness of the critical need for more reliable, effective, and accessible ways to recognize those in need, direct them to help, and ensure that they receive the best evidence-based care available. AboutFace is a novel peer education program that features the personal stories of Veterans and is designed to improve Veterans’ likelihood of engaging in PTSD specialty care. Using a randomized controlled study design we propose to compare the efficacy of AboutFace relative to standard care for improving treatment engagement and outcomes. Additional data from VA providers will provide valuable information on wide scale implementation and dissemination of AboutFace. If AboutFace increases access of services, data will have broad implications for overcoming barriers to care for Veterans with PTSD and other stigmatized conditions.